Career Enhancement Program

Project Summary/Abstract
The overall goal of the Career Enhancement Program is to attract, select, and mentor promising junior
scientists with a special emphasis on recruiting qualified women, individuals from underrepresented racial and
ethnic groups, as well as individuals with disabilities, and to support awardees’ rigorous and innovative
translational research projects addressing cervical cancer. The Cervical Cancer SPORE recognizes that a
sustained, dynamic, and cutting-edge program to improve patient outcomes is dependent upon attracting the
most promising junior investigators to study cervical cancer, and supporting their careers. We further recognize
the importance of seeking out such talent among underrepresented groups, notably racial and ethnic minorities,
women, veterans, and individuals with disabilities, who have been disadvantaged, and helping these faculty
members flourish as independent scientists through thoughtful mentorship and practical help. Candidates submit
an application and are evaluated through a careful selection process involving a Career Enhancement
Committee headed by Dr. T.-C. Wu, the SPORE PI and Co-Leader of the Career Enhancement Program at
Johns Hopkins University (JHU), as well as the SPORE Steering Committee. Dr. Donald Buchsbaum, the Co-
Leader of the Career Enhancement Program from the University of Alabama at Birmingham (UAB) assists in the
basic science efforts of awarded investigators. Recipients of the award are reviewed annually and investigators
are required to submit an annual progress report subject to the aforementioned review process. In addition, the
Sidney Kimmel Comprehensive Cancer Center at Johns Hopkins provides $75,000 annually as match funds for
the Career Enhancement Program. UAB will also contribute $50,000 annually to be used to fund Career
Enhancement Projects. The Johns Hopkins Vice Provost for Research has also agreed to contribute one Catalyst
Award of $75,000, which is intended to support the promising research and creative endeavors of an early career
faculty member. This continues to be an impactful program that has recruited and developed a cadre of
outstanding translational scientists, including several new leaders in this Cervical Cancer SPORE, and
incorporated their innovations and expertise into this Program.

Public health relevance
Project Narrative The Career Enhancement Program is critical to the rejuvenation of the Cervical Cancer SPORE Program by recruiting the best junior faculty to focus on cervical cancer research. We plan to attract, select, and mentor promising junior investigators with a special emphasis on recruiting qualified women, individuals from underrepresented racial and ethnic groups, as well as individuals with disabilities. The Cervical Cancer SPORE will support Career Enhancement Program awardees’ rigorous and innovative translational research projects addressing cervical cancer.